Dissecting the role of the Inclusion membrane protein IncE, a master multi-tasking scaffolding protein, in the pathogenesis of Chlamydia trachomatis infections

Abstract
Chlamydia trachomatis (Ct) infections are important causes of human disease for which no vaccine exists.
An important gap in our knowledge is how this obligate intracellular vacuolar bacterium establishes a privileged
niche--a membrane bound compartment termed the inclusion. Chlamydia encode a distinctive family of secreted
effectors, the Incs (Inclusion membrane proteins), which are translocated from the bacteria through the type III
secretion system and inserted into the inclusion membrane. We have discovered that an early expressed Inc,
IncE, binds to two different host cell protein complexes that are involved in trafficking, sorting nexins (SNX)5 and
6 as well as two closely related Q-SNARES, Syntaxin(STX)7 and STX12, which are involved in late and early
endosome trafficking, respectively. Our results support a model wherein IncE directly binds SNX5/6, which
redirects the ESCPE-1 complex (SNX5/6 together with SNX1/2) to the inclusion membrane, potentially disrupting
ESCPE-1-mediated trafficking. In preliminary experiments, we have defined the regions of IncE that are
necessary for binding to STX7/12 and discovered that IncE encodes an additional distinct short motif separate
from the SNX5/6 cargo binding motif that mimics the zero layer motif (ZLM) of the VAMP3 family of R-SNARE
proteins, known binding partners of STX7/12. This exciting observation suggests that IncE may modulate
STX7/12 vesicle fusion with the inclusion, either by stimulating it, inhibiting it, or functioning as a tether. Using
RNAi, we have discovered that STX7 and STX12 serve distinct non-overlapping roles in Ct infection. We have
created an IncE null mutant and complemented it with informative IncE variants. This heroic application of Ct
genetics will allow us to separate IncE binding to SNX5/6 from its binding to STX7/12, and to test the role of a
single Inc in an animal model of Ct genital tract infection. In this grant, we propose to employ a combination of
Ct genetics, cell biology, advanced microscopy, and biochemistry to: Aim 1. Determine the role of IncE in the
pathogenesis of Ct infections. We will characterize the phenotypes of the IncE in-frame deletion mutant strain
and informative isogenic complemented derivatives using (A) cell-based assays and (B) a mouse model of upper
genital tract infection. Aim 2. Understand the molecular mechanism and consequences of IncE:STX7/12
interactions. Using informative IncE mutant strains and proteins, we will (A) determine whether IncE:STX7/12
interactions modulate fusion, using live cell microscopy that employs novel fluorescent lipid probes (B) determine
if IncE, and specifically its ZLM, is sufficient to modulate STX7 vesicle fusion, using an in vitro liposome fusion
assay; (C) test the hypothesis that the IncE ZLM binds directly to STX7 and/or STX12, using purified proteins;
ad (D) Test whether IncE can bind simultaneously to STX7/12 and SNX5/6; Aim 3. Decode the roles of
STX7/12 in regulating the Ct intracellular lifecycle. We will investigate (A) how STX12 contributes to
homotypic inclusion fusion; (B) how STX7 contributes inclusion formation and production of infectious progeny.
Our studies will increase our knowledge of host cell biology and reveal how microbes subvert these processes.

Public health relevance
Project Narrative Chlamydia species are obligate intracellular bacteria that are leading causes of ocular, genital, and respiratory infections in humans. This grant seeks to understand how Chlamydia survives within the hostile intracellular environment.